Imaging macromolecular machines in gene regulation

Research in my laboratory is focused on understanding the structure and function of
macromolecular machines using cryo-electron microscopy (cryo-EM). There are three broad
avenues of investigation: (1) mechanisms of RNA-guided CRISPR-Cas surveillance (2)
methods to solve structures of human complexes in a highly parallel manner, and (3)
understanding nucleic acid processing machines, including ribosomes and RNA polymerases.
We are fundamentally interested in understanding how molecular machines are assembled and
perform their myriads of functions. We use multidisciplinary approaches to perform detailed
mechanistic studies that, in the end, lead to high impact work and broad applications. Here, I
propose how our approach of studying basic enzymology will lead to important insights into (a)
how Cas9 can function as a multi- turnover enzyme, (b) how PRIME editors recognize and edit
DNA targets, (c) the structure and function of retrons, and (d) determining the mechanisms of
novel antiviral defense systems in bacteria.

Public health relevance
Project Narrative My laboratory uses structural biology to interrogate machines that are capable of editing genes associated with diseases and are the future of precision medicine. By analyzing these structures, we will learn the fundamentals of how they work and how to reengineer them to make them more robust, accurate tools.